HIV Treatment Strategies for Female Sex Workers Living with HIV in South Africa: Engagement Trajectories and Implementation Determinants

PROJECT SUMMARY / ABSTRACT
Significance: Female sex workers (FSW) living with HIV are disproportionately marginalized and face a
myriad of barriers to sustained engagement in HIV care and viral suppression. In 2022, South Africa remains
the epicenter of HIV globally, and among FSW in the country, diverse experiences, vulnerabilities, and
treatment outcomes exist. Tailored, multifactorial implementation strategies to support HIV care and viral
suppression are needed for FSW whose needs are not being met, yet, it is not feasible nor effective to offer
everything to everyone.
Study Goal and Specific Aims: This study will provide a detailed understanding of when FSW engage with
implementation strategies to support HIV care and treatment, who engages, as well as how implementation
determinants influence outcomes, illuminating potential mechanisms for optimizing HIV treatment support
strategies. Specific Aims are to: 1) Identify patterns of engagement among FSW living with HIV and determine
their correlates and association with retention and viral suppression over time; 2) Explore how fidelity of
strategy implementation (i.e., strategy dose administered) impacts the relationship between strategy exposure
and clinical outcomes among FSW living with HIV; and 3) Characterize contextual factors influencing strategy
implementation and the effect on retention and viral suppression among FSW living with HIV.
Approach: This study will leverage existing quantitative, qualitative, and implementation data and
infrastructure of the Siyaphambili trial. The Siyaphambili study employed a sequential multiple assignment
randomized trial to test two implementation strategies among a cohort of 777 non-virally suppressed FSW
living with HIV over an 18-month follow-up period. The proposed study utilizes group-based trajectory modeling
to identify distinct trajectories of longitudinal FSW engagement (Aim 1), a component path analysis to explore
the role of programmatic implementation fidelity (Aim 2), and a moderator analysis to characterize
implementation determinants, interpreted and contextualized through in-depth interviews (Aim 3). All proposed
Aims represent novel analyses of existing, cleaned data collected from the Siyaphambili study.
Fellowship information: The proposed research is the doctoral dissertation of Ms. Carly Comins. The training
plan consists of selected coursework, tailored ongoing mentorship, and professional development to foster the
successful completion of the proposed research and to prepare Ms. Comins to become an independent HIV
epidemiologist and implementation scientist supporting HIV-related implementation research for key
populations. The proposed study directly aligns with the NIMH’s goals and the priorities of the Division of AIDS
Research, including leveraging pragmatic effectiveness-implementation research to enhance understanding of
the real-world impact of evidence-based interventions; improving methods to match interventions to
marginalized populations; and optimizing the delivery and reach of interventions among those at greatest need.

Public health relevance
PROJECT NARRATIVE The burden of HIV among female sex workers (FSW) in South Africa is disproportionally high and addressing the treatment needs of FSW is critical to supporting optimal health and wellbeing, reducing onward transmission, and altering the HIV epidemic; how to feasibly and effectively implement strategies to support the unmet needs of those most marginalized remains often unclear. This study will leverage existing data collected over 18-months among a cohort of 777 non-virally suppressed FSW living with HIV to understanding longitudinal patterns of engagement with HIV treatment support strategies, the role engagement had on sustained retention and viral suppression, and the mechanisms through which implementation outcomes (i.e., fidelity, feasibility, and appropriateness) influenced sustained retention and viral suppression. Results will inform the measurement, optimization, and dissemination of HIV implementation strategies aimed to increase HIV treatment access, retention, and viral suppression among FSW living with HIV at greatest need.